Digital speech markers for early detection of Alzheimer’s disease in a longitudinal racially and ethnically diverse cohort

PROJECT SUMMARY/ABSTRACT
-
modifying treatments become available. Traditional diagnostic methods, primarily episodic memory
assessments, are often inadequate in the early stages, missing subtle cognitive shifts that occur years before
clinical symptoms are apparent. Language impairments, such as difficulties with word retrieval, emerge as early
markers of AD, yet remain underutilized in clinical settings. Automated speech analysis offers a non-invasive,
scalable, and cost-effective approach to detecting these early signs by analyzing spontaneous speech patterns.
The objective of this project is to develop and validate an AD-specific speech profile using automated speech
analysis to improve early detection and monitoring of AD. Leveraging existing and newly collected longitudinal
speech samples from culturally and educationally diverse populations, we will use cutting-edge machine learning
algorithms to identify key linguistic and acoustic features indicative of cognitive decline. Our large and
diagnostically diverse cohorts will enable us to distinguish between different stages of AD and differentiate AD
from other neurodegenerative diseases such as primary progressive aphasia and frontotemporal dementia. Aim
1 focuses on developing a sensitive and specific AD-speech profile to classify clinical diagnoses and predict the
transition from preclinical to clinical AD. Aim 2 investigates the clinical validity of the AD-speech profile by
correlating it with established neuroimaging biomarkers (e.g., amyloid-PET, MRI) and cognitive measures while
accounting for sociodemographic influences. Aim 3 aims to establish the reproducibility and generalizability of
the speech profile by externally validating it with an independent cohort. This multidisciplinary project brings
together expertise in neurology, linguistics, neuropsychology, biostatistics, and digital health to create an
accessible, objective tool that enhances early detection and monitoring across racially and ethnically diverse
populations. By focusing on subtle changes in language patterns, the project lays the foundation for automated
speech analysis as a clinically viable and equitable method for early AD diagnosis and disease monitoring.

Public health relevance
PROJECT NARRATIVE This research project seeks to harness the power of automated speech analysis to advance early detection of Alzheimer's disease, a condition that affects millions of individuals worldwide and poses significant challenges to healthcare systems. We still lack sensitive, low-cost, and high-access cognitive markers to reliably detect and track the earliest cognitive manifestations of needed to understand heterogeneity in clinical presentations, aid diagnosis and prognosis, and provide sensitive outcome measures for clinical trial research. Language impairment is among the first symptoms of Alzheimer yet remains underutilized in clinical assessment; by identifying and validating digital speech markers, our work aims to fill critical gaps in current diagnostic methods, offering an automated, non-invasive, cost-effective tool for identifying early cognitive changes associated with A .